Transcriptional Regulation of Myogenesis

Defining the gene expression cascade underlying cell fate determination is a key element in understanding development and diseases that arise due to mis-regulation. The availability of whole genome microarrays, coupled with the isolation of nearly pure cell type populations, allows one to begin to define the transcriptome associated with specific cell fates. Muscle cells have been attractive targets for such studies in mature animals due to their ease of isolation and_or culture and their importance in human pathologies. It has been more difficult, however, to determine early in vivo embryonic myogenic gene expression patterns that would give insights into the regulation of muscle development. To this end, we have done a developmental profile of gene expression and identified key transcriptional regulators. We continue to study the in vivo target genes activated by the myogenic regulator, HLH-1,a homolog of the vertebrate MyoD family. We have previously shown that ectopic expression of hlh-1 in early C. elegans embryos is sufficient to convert most blastomeres to a body wall muscle like fate. To define the transcriptional targets of HLH-1 that underlie muscle cell fate specification and differentiation, we have use chromatin immunoprecipitation (ChIP) followed by probing whole genome tilling microarrays (Chip) or, in collaboration with the Reinke lab, ChIPed samples are subjected to next generation sequencing. The results reveal that the in vivo binding sites for this transcription factor are widespread throughout the genome, similar to what has recently been reported in the mouse. This strongly suggests that these master regulators of myogenesis are acting to control more than just downstream target gene activation, perhaps being also involved in chromatin organization.